Anti-NMDA Receptor Antibodies in Adult Brain Dysfunction: Lessons from Lupus

Abstract - Overall
This is a proposal to continue highly integrated studies of neuropsychiatric manifestations of Systemic Lupus
Erythematosus such as cognitive impairment, anxiety, depression and fatigue in a patient cohort and a mouse
model that phenocopies many aspects of the human disease. The goal of these projects are to identify
mechanisms of disease and both therapeutic targets and therapeutic strategies.
A major overall goal is to identify patient heterogeneity that can be studied at the cellular and molecular level in
mice.
The studies are supported by four Cores. The Administrative Core maintains regulatory compliance and assists
in preparation of manuscripts and reports. A Monoclonal Antibody and Reagent Core ensures the integrity of
reagents and assays used in both projects. An Animal Behavior and Electrophysiology Core performs
standardized behavioral assessments of mice and EEGs on human subjects. A Clinical Core coordinates the
generation of a single database for all patients and seeks to identify subsets of patients that have a
neurocognitive and behavior features analogous to our mouse models.

Public health relevance
Narrative This is a continuation of a very productive program to study neuropsychiatric manifestations of Systemic Lupus Erythematosus, cognitive impairment, anxiety, depression and fatigue, and to model the human disease in mice to permit a cellular and molecular characterization of brain dysfunction.